Black Hazardous Drinkers: Ecological Momentary Assessment of Racial/Ethnic Microaggressions

Project Summary/Abstract
Despite being one of the largest racial minority groups in the United States (U.S.), Black individuals experience
striking health disparities, particularly in terms of drinking-related outcomes. One possible reason for this is that
Black individuals in the U.S. are disproportionately affected by stressful life conditions, including race-based
discrimination, which may lead to higher rates of hazardous drinking. Subtle race-based discrimination at the
daily level, known as racial/ethnic microaggressions (MAs), is common among Black persons, and may be an
under recognized factor that accounts for significant and unique variance in alcohol use motivation and
hazardous drinking. The goal of this R21 project, which is in direct response to PA #20-195, is to elucidate the
role of MAs in hazardous drinking and alcohol use motivation among Black individuals using time sampling
methodology (over the course of 21 days). Participants (N=100; 50% female) will be Black adults meeting
criteria for current hazardous drinking. Further, the present proposal will determine whether negative affect
(e.g., anxiety, depression, anger) in response to MA accounts for the relation between MAs and alcohol use
motivation (i.e., greater alcohol craving, intention to drink, and coping-oriented motives for alcohol use) and
drinking (i.e., greater alcohol consumption, greater frequency of drinking, and more negative consequences
from drinking), and test theoretically driven culturally relevant resilience factors, including religiosity and ethnic
identity, and positive coping strategies. This proposal can significantly advance our knowledge of precursors to
alcohol misuse and related problems within the Black community and provide critical insight for future
prevention and intervention programs. The proposed research project supports the 2022-2026 proposed
strategic plan of the National Institute of National Institute on Alcohol Abuse and Alcoholism (NIAAA) by
addressing cross-cutting themes such as: (1) promoting health equity and enhance diversity and inclusion in
the alcohol research enterprise, and (2) advancing research on co-occurring conditions (in this case, race-
based stress and associated negative affect) that interact with alcohol misuse; it further addresses the strategic
plan’s goal to “identify and track the biological, social, environmental, and behavioral causes and
consequences of alcohol misuse.” Further, the proposed project is in line with NIH’s UNITE initiative’s aim to
support “new research on health disparities, minority health, and health equity”.

Public health relevance
Project Narrative Hazardous drinking among Black individuals in the United States poses a major public health concern. The proposed research aims to better understand antecedents of alcohol use motivation and hazardous drinking among this population by examining racial/ethnic microaggressions (MAs) – brief, subtle forms of everyday discrimination due to racial/ethnic status – that may prompt Black persons to be more motivated to drink to mitigate MA-related negative affect and engage in risky patterns of alcohol use. Through this research, we also will explore mediational processes and moderators in the MA-hazardous drinking relations that will inform future intervention and prevention efforts for this neglected health disparities group.